Development of selective cannabinoid receptor 2 agonists for treatment of addiction

Project Summary
America currently faces a dire epidemic of substance use disorders. In 2019, 20.4 million Americans aged
12 or older had a substance use disorder. Approximately 1.6 million suffer from opioid use disorder, which
causes more than 136 overdose deaths per day on average. Stimulant abuse is also a significant contributor
to this social crisis' extension and severity, with 1 million suffering from methamphetamine use disorder (MUD)
and another 1 million from cocaine use disorder. Methamphetamine and cocaine are currently major causes
of overdose deaths behind opioids for illicit drugs. Methadone and buprenorphine are widely used treatments
for opioid addiction, but there is currently no approved pharmacological treatment for stimulant use disorder
(SUD). Thus, there is an urgent need to develop pharmacological interventions for SUD. Medical marijuana
has been associated with reduced opioid prescription rates and deaths, and preclinical studies show that
cannabinoids affect addictive-like behavior. These effects are believed to be mediated by cannabinoid
receptors in the brain. The cannabinoid receptors 1 and 2 (CB1R and CB2R, respectively) are part of the
endocannabinoid system and play a crucial role in modulating dopamine (DA) levels in the central nervous
system (CNS). Marijuana and nonselective cannabinoids such as THC can activate both CB1R and CB2R.
While extensive effort has been invested in understanding the role of CB1R in this DA system, the addictive
and psychoactive properties of cannabinoids are also associated with the activation of CB1R. The recent
discovery of inhibitory CB2 receptors in the ventral tegmental area (VTA) DA neurons and their inhibitory role
in the dopaminergic circuit, leading to reduced DA release in nucleus accumbens (NAc), as well as a receptor
modulating glial and microglia function in the CNS, has created a new opportunity for targeting this pathway
for therapeutic development. With support from a U18 NIDA pilot grant for the past year, we have successfully
identified a lead series of novel chemical entities (NCEs) that display functional selectivity for cyclase over
arrestin (i.e., biased) and are also very selective for CB2R with minimal activity for CB1R. Our lead candidate
has good oral absorption, brain penetration and, in animal models, reverses the addictive behavior of mice.
This proposal aims to further optimize our lead compound as a preclinical/clinical candidate for the treatment
of MUD. While displaying excellent selectivity for CB2R over CB1R, our lead compound has residual arrestin
activity and needs further PK optimization. We have put together a panel of multidisciplinary experts covering
CNS pharmacology, medicinal chemistry, biology, and preclinical and clinical addiction medicine and
psychiatry to further support the development of this class of compounds with the help of the Blueprint
Neurotherapeutics Network (BPN) before testing in humans.

Public health relevance
Project Narrative While the recent national focus has been on the opioid crisis, 1 million Americans suffer from methamphetamine use disorder and 1 million more from cocaine use disorder, with stimulants being the second leading cause of overdose deaths behind opioids. However, unlike opioids, there is currently no pharmacological treatment approved by the FDA for stimulants. This project aims to collaborate with the Blueprint Neurotherapeutics Network (BPN) team for lead optimization of our novel, cyclase-biased, selective cannabinoid receptor 2 (CB2R) agonists class, developed at Stanford with support from a U18 NIDA pilot grant, into preclinical/clinical development for the treatment of methamphetamine use disorder.